Calming the Cytokine Storm: Unraveling the Biology of CRS and ICANS

PROJECT SUMMARY/ABSTRACT
Chimeric antigen receptor T-cells (CART) have revolutionized cancer therapy. However, CART cause two
common and severe toxicities: Cytokine Release Syndrome (CRS) and Immune Effector Cell Associated
Neurotoxicity Syndrome (ICANS). CRS and ICANS are overlapping phenomena that occur with a spectrum of
severity from mild to life threatening. Effective therapies for CRS currently exist but severe refractory cases still
occur. Effective therapies for ICANS are lacking. The pathophysiology of CRS and ICANS have not yet been
fully defined, precluding development and translation of novel therapies. In particular, the role of the host
innate immune system in these conditions is poorly understood.
The specific objective of this project is to identify the cellular and cytokine initiators of CRS and the role of
complement and the inflammasome in the biology of ICANS. In Specific Aim 1, the candidate will determine the
number and transcriptional activation state of different monocyte and non-monocyte populations associated
with CRS using single cell RNA sequencing (scRNAseq) and test the role of novel monocyte produced
cytokines in the priming and initiation of CRS. In Specific Aim 2, the candidate will dissect the role of the
inflammasome and complement dysregulation in the development of ICANS, and test individual and combined
approaches for inflammasome and complement blockade in preventing and treating ICANS.
The candidate is a pediatric oncologist committed to understanding immune dysregulation disorders that occur
as a consequence of cancer immunotherapy. The proposed training plan and research project will be
conducted at the Children's Hospital of Philadelphia (CHOP) and the University of Pennsylvania (UPENN).
CHOP and UPENN are leaders in cellular immunotherapies and basic and clinical immunology and will provide
an outstanding environment in which to conduct the proposed research. Throughout the period of the award
the candidate will be mentored by Dr. David Teachey and a very strong advisory committee including Drs. Ed
Behrens, Marcela Maus, Wenchao Song and Stephan Grupp. The long-term goal of the candidate is to
develop a research program devoted to understanding the role of the innate immune system in immune
dysregulation related to cancer immunotherapies, and improving the health of patients by facilitating translation
of less toxic, more effective immunotherapies. Completion of the proposed research project and the
complementary training plan will provide a robust foundation to achieve this goal.

Public health relevance
PROJECT NARRATIVE Chimeric antigen receptor T-cells (CART) have revolutionized the treatment of relapsed or refractory B-cell acute lymphoblastic leukemia (B-ALL) and improved survival rates in this population. However, CART can cause severe immune dysregulation disorders that we do not fully understand. This proposal will define the mechanistic biology of immune dysregulation disorders occurring post CART and test potential novel therapies for the treatment of these disorders.